Enabling Molecular Approaches for Copper-Based Radiopharmaceuticals

As access to cyclotron sources have become more readily available, radioisotopes of copper
(e.g., 64Cu: β+ = 653 keV, t1/2 = 12.7 h; 67Cu: β- = 141 keV, t1/2 = 61.9 h) have received increasing
attention for imaging and therapy due to their sensitivity, resolution, and half-life compared to
other radionuclei (e.g., 11C, 18F, 68Ga). The overwhelming majority of active 64Cu or 67Cu clinical
trials, as well as the FDA approved 64Cu radiopharmaceutical, [64Cu][Cu(DOTATATE)]
(DetectnetTM), employ bifunctional chelators (BFCs) based on macrocyclic
polyaminocarboxylates. These BFC form thermodynamically and kinetically stable copper
complexes and display promising performance in head-to-head clinical trials; however,
applications of Cu-based radiopharmaceuticals have been limited by their in vivo stability (i.e.,
reduced imaging sensitivity and increased off-target radiation to organs and tissues). Despite
significant clinical attention and >25 years of BFC development, fundamental knowledge
underpinning improvement-driven design (i.e., structure, reactivity, mechanisms of metal-loss)
remain limited. In this research project, we will overcome longstanding challenges in the
development of copper-based radiopharmaceuticals through advancing the designs of BFC with
exceptional in vivo kinetic stability. Our mechanistically-driven study employs an interdisciplinary
approach that embeds a tight feedback loop between novel BFC design, in vitro, and in vivo
studies capable of enabling target-driven improvements in radiopharmaceutical performance.
This approach will develop quantitative structure-function relationships bridging molecular-level
BFC attributes with radiopharmaceutical properties and performance in vivo, and resolve
longstanding questions regarding relevant pathways and (bio)molecular targets responsible for
kinetic (in)stability in vivo. Knowledge gained in this study will contribute to improved BFC designs,
which should serve as platforms to expand applications in imaging and therapy of a range of
human diseases (e.g., prostate cancer, breast cancer, heart disease).

Public health relevance
Project Narrative Enhancing the sensitivity and resolution of metal-based radiopharmaceuticals is critical for early- stage detection and treatment of key diseases, including many types of cancer. Despite the promise of copper-based radioisotopes for high-impact theranostic applications (imaging + therapy), their applications have been limited by their stability in vivo. Our interdisciplinary research program will address this longstanding challenge through fundamental, improvement- driven chelator design and carefully design model systems which will uncover critical connections between molecular structure, properties, and in vivo of copper radiopharmaceuticals.